Technology Core

Abstract - Technology Core
This U19 proposes a novel and fully integrated approach to understanding disease progression and treatment
response in tuberculosis (TB). We will combine traditional approaches to understanding the pathophysiology of
TB, bacterial genetics and immunology, with systems biology approaches including genomics, transcriptomics,
metabolomics, lipidomics, proteomics, and computational modeling. We will apply HTP “Omics” technologies
and systems analysis to murine and mycobacterial studies and to human field studies in tuberculosis. Data
generated by HTP and targeted state-of-the-art approaches will be integrated through bioinformatic and
modeling approaches, which, combined with domain expertise, will lead to a deep understanding of the
molecular networks that underlie the progression of TB infection and response to treatment, and predict
complex biological behaviors that lead to either containment or active disease; treatment cure or relapse.
Multiple innovative HTP technologies will be leveraged and enhanced through this program. These
technologies have been established in multiple experimental systems and will be customized and further
developed for their application to this program and to clinical samples as appropriate. These developments will
ensure data quality, and maximize the efficiency of data generation. The approaches chosen are innovative
and state-of-the-art and will maximize our ability to complement and extend the existing comprehensive
network models and provide spatial perspective for models generated as part of the original OTB program. We
will disseminate modifications and improvements to extant technologies and detailed protocols broadly to
enable adoption and further development by the community.